Mucosal Delivery and Retention of Ebola Inhibitor Scytovirin Using Lactobacillus

Abstract A natural protein molecule, scytovirin (SVN) from cyanobacteria has been found to have a strong inhibitory activity against Ebola infection. This project will utilize the anti-viral property of scytovirin and in combination with lactic acid bacteria (LAB) to build up an anti-Ebola inhibitor mucosal delivery approach for the control of Ebola infection and transmission. This bacteria-based approach will be effective because the SVN inhibitor can be directly delivered at the mucosal surfaces right at the ports of viral entry. These anti-Ebola bacteria may not only be utilized for prevention, but also for treatment. Because the LAB can colonize in human body, a long- term efficacy could be achieved. This approach is also simple and cost-effective that can be easily used and managed in the regions of Ebola outbreaks and especially in the developing countries.

Public health relevance
Project Narrative This project is to utilize Lactobacillus to produce scytovrin (SVN), a natural inhibitor to combat Ebolavirus (EBOV) infection and transmission. Because the Lactobacillus can colonize and replicate in our body, this approach could create a long-term efficacy for the control of EBOV outbreaks and epidemic.